Sequence-function relationship of influenza broadly neutralizing antibodies

PROJECT SUMMARY
Influenza A virus continues to be a major global health concern due to antigenic drifts and shifts. Rapid
antigenic drifts of circulating human influenza subtypes (H1N1 and H3N2), which are caused by point
mutations, can drastically hamper vaccine effectiveness despite annual update of the seasonal influenza
vaccine. On the other hand, antigenic shifts, which are caused by genetic reassortment between antigenically
distinct strains, can result in devastating pandemic as exemplified by the 1918 Spanish flu. Human infections
with different zoonotic subtypes, such as H5N1, H6N1, H7N9, H9N2, and H10N8 have also been reported. As
a result, a universal influenza vaccine that can elicit broadly protective antibody responses to diverse influenza
strains and subtypes is urgently needed. The discovery of broadly neutralizing antibodies (bnAbs) that target
the conserved stem region of influenza hemagglutinin (HA) has raised the possibility of developing a universal
influenza vaccine. A number of HA stem bnAbs are encoded by immunoglobulin heavy chain germline gene
IGHV6-1. Since these IGHV6-1 HA stem bnAbs can be found in multiple individuals and can cross-react with
both group 1 HAs (H1, H2, H5, H6, H8, H9, H11, H12, H13, and H16) and group 2 HAs (H3, H4, H7, H10, H14,
and H15), they represent the type of antibody response that needs to be induced by a universal influenza
vaccine. This proposed study will use innovative high-throughput experiments to define sequence features in
the heavy-chain complementarity-determining region 3, light chain, and somatic hypermutations, that enable
an IGHV6-1 antibody to be a cross-group HA stem bnAbs. The underlying molecular mechanisms will be
further characterized by structural biology approach. The results will help accurately estimate the germline
frequency of IGHV6-1 HA stem bnAbs and understand their affinity maturation pathway, which in turn will
benefit the design of a universal influenza vaccine. Furthermore, the experimental framework established in
this study will be applicable to characterize any antibody of interest.

Public health relevance
PROJECT NARRATIVE Immunoglobulin heavy chain germline gene IGHV6-1 encodes a multi-donor class of broadly neutralizing antibodies (bnAbs) to the highly conserved stem region of hemagglutinin (HA). This proposed study aims to characterize the sequence features and affinity maturation pathways of IGHV6-1 HA stem bnAbs. The results will provide important mechanistic insight into the development of universal influenza vaccines.